An NADH-ChREBP axis in fatty liver disease and dyslipidemia

Project Summary/Abstract
Despite being the most common forms of liver disease, alcohol and non-alcoholic fatty liver disease (AFLD and
NAFLD) have no effective medical therapies. We must better understand the metabolic causes of these
conditions to develop new treatments. The long term goal of this work is to understand how elevated hepatic
NADH levels influence metabolism leading to pathogenic metabolic traits such as fatty liver and dyslipidemia,
and use this insight to develop new treatments for these conditions. We have found that elevated NADH levels
are a feature of AFLD, NAFLD, and a common GCKR P446L variant which causes hepatic fat accumulation in
humans. By using a new metabolic tool, LbNOX, to alter hepatic NADH levels in mice we have found that
NADH activates the lipogenic transcriptional factor ChREBP. Our overall objective is to determine how
elevated hepatic NADH leads to hepatic fat accumulation and dyslipidemia. Our central hypothesis is that
elevated NADH levels are a common mechanism leading to hepatic fat accumulation and dyslipidemia in both
NAFLD and AFLD through activation of the transcription factor ChREBP, and that hepatic NADH can be
directly targeted for beneficial metabolic effect. The rationale for this proposal is that showing elevated NADH
has a casual role in the development of NAFLD and AFLD would validate lowering hepatic NADH as a
therapeutic strategy to treat these conditions. Our central hypothesis will be tested by pursuing three specific
aims: (1) We will define the ChREBP and NADH-dependent transcriptional and metabolic effects of GCKR
446L through the use of human liver organoids (HLOs) we have engineered to have different GCKR
genotypes. (2) We will determine the in vivo role of an NADH-ChREBP axis in mouse models of NAFLD and
AFLD using newly generated transgenic LbNOX mice. (3) We will identify novel genetic regulators of elevated
hepatic NADH and their relationship between hepatic fat and ChREBP activation using a large genetically
diverse outbred mouse cohort. The proposed work is significant because demonstrating the role of an NADH-
ChREBP axis in fatty liver disease will inspire new therapeutic strategies directly targeting hepatic NADH. This
work is innovative as it uses a combination of new metabolic tools and approaches to study metabolic disease
– including transgenic LbNOX mice and human liver organoids – as well as insights gained from human
genetics to understand and define the importance of this metabolic pathway.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because understanding how elevated NADH contributes to non-alcoholic and alcoholic fatty liver disease will enable novel approaches to treat these conditions, which are the most common forms of liver disease in the United States but which have no effective pharmacologic therapies. Thus, the proposed project is relevant to the NIH’s mission to seek and apply knowledge to lengthen life and reduce illness.